SIMULATION OF COMPLEX MULTIDIMENSIONAL DIFFUSION PHENOMENA IN MAGNETIC RESONANCE

Diffusion of water, as detected by MRI, can reveal microscopic structures in tissues. Understanding of these phenomena requires extensive simulations as well as theory and experiments.